Characterizing the spectrum of genomic and phenotypic variation in cerebral palsy

PROJECT SUMMARY/ABSTRACT
Cerebral palsy (CP) is a common (prevalence 1 in 500), nonprogressive developmental brain disorder (DBD)
characterized by neuromotor impairments often accompanied by other neurodevelopmental and medical
disorders. Birth asphyxia, long considered the most frequent cause of CP, accounts for <10% of cases and a
specific cause remains unknown for most individuals. A growing body of evidence suggests that a large
proportion of CP is caused by rare genomic variants, as has been shown for other DBDs. Additionally, the
contribution of common genomic variants to CP has not been adequately evaluated. Here, we propose to
elucidate the complete genomic architecture of CP, including the contribution of rare and common genomic
variants. We will capitalize on data generated from two complementary sources: 1) a pediatric CP cohort referred
for exome sequencing (ES) to a clinical genetics laboratory (GeneDx) and 2) an adult CP cohort from Geisinger’s
MyCode study, a large-scale genomics initiative with paired electronic health record (EHR), ES, and SNP
genotype data. As with other DBDs, clinical variability is common in CP and detailed genotype-phenotype
correlation studies are required to characterize the contributors to phenotypic variance. Similarly, neuroimaging
studies reveal brain abnormalities in 70-90% of individuals with CP; however, finding a neuroimaging abnormality
does not establish the underlying cause for most individuals without further evaluations and there is a lack of
neuroimaging studies to link genomic findings with CP. We will address these significant knowledge gaps through
the following aims: 1) Extract and standardize genomics, EHR, and neuroimaging data to create a large,
harmonized CP dataset for analysis. We will leverage genotype and phenotype data from 4,000 individuals with
CP and harmonize their available genomic, EHR, and neuroimaging data. 2) Determine the contribution of rare
genomic variants to the etiology of CP and identify new gene-disease relationships and CP-related genes; 3)
Evaluate the role of common genomic variants in CP and the influence of genomic liability for DBD on CP. We
will comprehensively assess the full genomic landscape of CP, including multiple classes of genomic variants.
4) Develop a genomically-informed approach to neuroimaging interpretation in CP and characterize genotype-
phenotype correlations for CP-related genes. We will perform genomically-informed neuroimaging interpretation
in a subgroup of participants with pathogenic variants to identify profiles of brain abnormalities related to specific
genes. We will also explore the contributors to clinical variability among individuals with rare variants in the same
gene. Overall, there is a very high likelihood of success that this project will lead to the identification of novel
genomic variants that cause CP. An immediate outcome of this study will be the generation of required evidence
to support the incorporation of clinical genomic testing into routine clinical care for individuals with CP. This
project will foster future research into molecular mechanisms of disease, which will be critical to developing
targeted therapies for specific genomic variants, and will inform clinical genomic testing for individuals with CP.

Public health relevance
PROJECT NARRATIVE Cerebral palsy (CP) is a common (prevalence 1 in 500) developmental brain disorder affecting early motor development, and although birth asphyxia was long considered the most frequent cause, it actually accounts for less than 10% of CP cases. Recent evidence, which requires further investigation, indicates that a large proportion of CP is likely genomic in origin. We propose a novel, cost-effective strategy to leverage genomic and clinical data from Geisinger’s healthcare-based population and referrals from a major clinical genetics laboratory to enroll individuals with CP and identify the critical regions of the genome and individual genes responsible for CP.